THE IMMUNOLOGY DATABASE AND ANALYSIS PORTAL (IMMPORT)

As a NIH funded publicly accessible data sharing platform, ImmPort supports immunology research and clinical studies. ImmPort offers curated datasets and reference datasets that adhere to the FAIR Principles and is one of the few trustworthy biomedical data repositories certified by CoreTrustSeal. Within ImmPort, there are two specific datasets that are suitable for NAIRR pilots due to their high level of AI-readiness: the 10K Immunomes Project and the COVID-19 compendium. ImmPort make use of AWS though the NIH STRIDES program that can become a component of the open NAIRR program.